Precise Infliximab Exposure and Pharmacodynamic Control to Achieve Deep Remission in Pediatric Crohn's Disease

Project Summary/Abstract
Crohn's disease is a chronic illness that results in intestinal inflammation and unwanted gastrointestinal
symptoms. The only biologic (monoclonal antibody) approved for moderate to severe Crohn's disease in children
(<18 years old) are those that antagonize tumor necrosis factor-alpha (anti-TNF). While there is a high initial
response rate to labeled infliximab (anti-TNF) dosing, only half of infliximab exposed patients will achieve clinical
remission and less than 40% will achieve endoscopic healing after one year on therapy. Several studies have
shown that rates of sustained corticosteroid-free remission are improved when patients receive anti-TNF dose
optimizations following reactive or proactive therapeutic drug monitoring. Moreover, anti-TNF dose intensification
following pharmacodynamic monitoring has led to improved rates of endoscopic (intestinal) healing. Therefore,
given the limited therapeutic options for children with active Crohn's disease, there is a critical unmet need for
the development of a data-driven, individualized, and scalable anti-TNF dosing intervention used from drug start
and continued throughout therapy to optimize drug exposure and ultimately, improve rates of intestinal healing.
Our team has developed a precision dosing strategy that uses an innovative physician decision support
dashboard that instantaneously applies pharmacokinetic model-informed precision dosing to generate an
individual infliximab dosing regimen starting with induction and targeting phase-specific pharmacokinetic and
pharmacodynamic endpoints throughout therapy. The central hypothesis is precision dosing (intervention arm)
with infliximab during induction and maintenance will improve rates of deep remission vs. conventional care
(pragmatic dosing; control arm). The central hypothesis will be tested with two specific aims. Aim1: Conduct a
cluster-randomized (by center) clinical trial to assess rates of deep remission at year1 between Crohn's
disease patients receiving infliximab with precision dosing vs. conventional care. Aim2: Refine model-
informed precision dosing using a continuous learning approach and identify anti-TNF PK/PD targets
from induction to maintenance associated with deep remission. Our approach is conceptually innovative
with an emphasis on practical implementation. This is the first clinical trial in children to provide anti-TNF dose
optimization during induction to target a specific early (week6) trough concentration while the maintenance
regimen is selected by specific treat-to-target pharmacokinetic and pharmacodynamic biomarkers. Additionally,
precision dosing regimens are produced with a novel web-based decision support dashboard and the study is
being performed within the ImproveCareNow Network to streamline clinical trial logistics. In Aim2, a continuous
learning approach will be applied to our published pharmacokinetic model to iteratively refine the model by
capturing new real-world data to better describe specific patient populations and further reduce prediction error.
The long-term goal is for the precision dosing strategy to generate a paradigm shift as the preferred dosing
approach to optimize exposure to all biologics and change the natural history of Crohn's disease.

Public health relevance
Project Narrative Crohn's disease is a chronic remitting and relapsing illness that results in intestinal inflammation, unwanted gastrointestinal symptoms and can lead to serious complications including surgery, hospitalizations, growth delays and poor quality of life. As there are limited treatment options approved for use in children and relapses are common, we will conduct a cluster-randomized clinical trial in children and young adults with moderate to severe Crohn's disease starting infliximab (anti-TNF). We will assess patient reported and disease modifying outcomes (endoscopic healing) between patients who received infliximab using an innovative, precision dosing strategy (treat-to-target) and those who received infliximab with the conventional dosing approach.